Improved RSV F Vaccine Candidates

Abstract Respiratory syncytial virus (RSV), a viral agent that causes severe respiratory illness, infects a large percentage of infants and children worldwide by the age of three (E. Heylen et al, 2017). According to the CDC, RSV is responsible for over 50,000 hospitalizations and 2.1 million outpatient visits among children younger than 5 years as well as 180,000 hospitalizations and 14,000 deaths among the elderly in the US alone (E. K. Miller, et al. 2013). After more than 40 years of research, several RSV vaccine candidates are in the pipeline, but none have progressed through the final approval process. A major target for vaccine development has been guided by the successful prophylactic use of a neutralizing monoclonal antibody, palivizumab (SynergisR) which is directed against the fusion glycoprotein (F protein). The treatment is expensive, must be given every 3-6 months for maximum protection, and is currently limited to high-risk young pediatric patients (E. Heylen et al, 2017). Clinical studies with unmodified F protein stimulates some neutralizing antibodies, but also non-neutralizing antibodies. We hypothesize that the non-neutralizing antibodies interfere with the action of neutralizing antibodies and that their elimination may improve the protective immunity stimulated by rationally-designed F variants. Guided by our previous work with HIV, Influenza, HRV, and most recently with RSV, we analyzed structural and immunological data for the F protein RSV to identify and immune dampen non- neutralizing epitopes. In a preliminary study, we designed and produced a panel of immune refocused F antigens and showed that the most promising candidates retained binding to neutralizing antibodies while losing binding to non-neutralizing antibodies. We propose to examine these types of F variants in both pre- and post-fusion conformations for improved protection in a cotton rat challenge study.

Public health relevance
Narrative RSV infections are a leading cause of respiratory illness and bronchiolitis in infants, the elderly, and the immunosuppressed. Prophylaxis in at-risk infant populations is based on perfusion with the neutralizing monoclonal antibody, Synagis, to establish passive immunity. Several vaccines are in the development pipeline including a number which are based on the F glycoprotein. Immunization with some of the most advanced candidates have failed to meet clinical endpoints. It appears from structural studies that F protein, while a critical target for inducing Synagis-like and other neutralizing antibodies, a large fraction of non-neutralizing antibodies is made in humans infected with RSV. We hypothesize that these non- neutralizing antibodies interfere with the protective activities of neutralizing antibodies. We propose technology to dampen the immunogenicity of the non-neutralizing epitopes in both pre- and post-fusion F antigens and assess their protective immunity in a cotton rat challenge study.